Incorporating Geriatric Constructs into Management of Inflammatory Bowel Diseases in Older Adults

PROJECT SUMMARY AND ABSTRACT
This is a Beeson (K76) Emerging Leaders in Aging career development award for Bharati Kochar, MD, MS, a
physician-investigator and gastroenterologist specializing in inflammatory bowel diseases (IBD) with the long
term goal of advancing care for the growing, but understudied, population of older adults with gastroenterological
conditions. While IBD has traditionally afflicted young adults, adults ≥60 years are the fastest growing age group
with IBD and comprise at least 25% of the ambulatory patient population. However, older adults comprise <1%
of patients in IBD clinical trials. The expanding arsenal of immunosuppressive therapies include risks for
infections and thrombotic events, all of which occur more frequently in older adults. This proposal addresses the
urgent need to generate high quality data on IBD treatment safety, effectiveness and applicability to older adults
to optimize and effectively tailor treatments. Preliminary data revealed that frailty, measured both as an
accumulation of deficits and as a phenotype, is a construct pertinent in IBD. However, the relationship between
frailty, function, type of and response to IBD treatments and adverse events in older adults with IBD is unknown.
The goal of this proposal is to investigate the components of frailty and function in predicting adverse effects
with IBD treatments in older adults. The specific aims are to (1) retrospectively determine differential increased
risks for adverse events associated with a frailty index among initiators of classes of IBD treatments in adults
≥60 years and (2) prospectively delineate trajectories of phenotypic frailty by response to IBD treatment in adults
≥60 years. Data from these aims will inform (Aim 3a) the derivation a geriatric-informed adverse event risk
prediction model to identify older adults with IBD at greatest risk for infections, hospitalizations and worsening
self-reported function by type of IBD-treatment. The proposal will culminate by (Aim 3b) assessing the feasibility
of conducting an IBD-specific, geriatric-informed, assessment in clinical practice. These aims will result in the
first systematic application of geriatric principles to guide management of older adults with IBD and lay the
foundation for a program of independent investigation. Dr. Kochar will achieve these aims with the guidance of
an exceptional cross-disciplinary internationally renowned mentorship team and advisory team of national
leaders. Primary mentor Dr. Christine Ritchie is an expert on patient complexity in geriatrics, Dr. Andrew Chan
is an expert in chronic disease and colon cancer epidemiology and Dr. Ashwin Ananthakrishnan is an IBD
thought leader. This award also supports structured didactic, applied and experiential training in advanced
competing risk and prediction modeling, aging-research including expertise in frailty and function, designing a
patient decision aid and leadership development. The combination of unparalleled mentorship, in-depth training
and meaningful research aims at the intersection of her mentors’ expertise lays the foundation for Dr. Kochar to
develop a pathway to independent investigation. This work will position Dr. Kochar to be a leader at the
intersection of geriatrics and gastroenterology and develop a novel field of “Geriatric Gastroenterology.”

Public health relevance
PROJECT NARRATIVE Despite >25% of Americans with inflammatory bowel diseases (IBD) being ≥65 years, <1% are included in clinical trials of IBD medications, resulting in a lack of robust data on safety and efficacy of these medications in older adults. Immunosuppression, associated with substantial risks and benefits that may be amplified at older ages, is the mainstay of modern IBD treatment; however, we have no tools to tailor treatments for older adults. This proposal seeks to study the impact of geriatric constructs of frailty and function as adverse event risk mediators after immunosuppressive treatments for IBD and generate a risk prediction model that can expand treatment options for the heterogeneous population of older adults with IBD.